Targeting 6-Phosphofructo-2-Kinase to increase efficacy of CDK4/6 Inhibitors

This extension request seeks to expand our understanding of CDK4/6 resistance in breast cancer, building upon
the groundwork laid by the original grant. The primary focus of this proposal is to understand how altered
glutamine metabolism can be exploited as a vulnerability in breast cancer that has developed resistance to
CDK4/6 inhibitors. Our central hypothesis is that the aberrant metabolism of glutamine serves to sustain
resistance to CDK4/6 inhibition in breast cancer. The main goal is to leverage this identified vulnerability in order
to develop targeted therapies capable of eradicating drug-resistant forms of the disease. The specific aims of
this extension involve a comprehensive exploration of the role of c-MYC in driving glutamine-induced resistance.
This includes investigating c-MYC's role in global metabolic reprogramming, understanding the dependency of
increased glutamine metabolism on c-MYC, and examining fuel dependencies following the loss of c-MYC.
Additionally, the metabolic fate of glutamine in CDK4/6-resistant cells will be examined. Furthermore, the
proposal aims to evaluate the therapeutic efficacy of a novel glutamine antagonist prodrug (JHU083) in patient-
derived xenograft (PDX) models of palbociclib-resistant breast cancer. This extension request represents a
significant and logical progression from the initial grant, introducing a pioneering evaluation of a novel glutamine
antagonist prodrug to target glutamine addiction in ER+ CDK4/6-resistant breast cancer. Anticipating that our
studies will yield crucial insights into overcoming drug resistance in breast cancer, we aim to contribute
meaningful therapeutic options for a subset of patients currently lacking effective treatment alternatives.

Public health relevance
While clinical responses to CDK4/6 inhibition have shown remarkable efficacy, metastatic breast cancer remains an unresolved challenge. The proposed studies aim to establish the mechanistic foundation for targeting glutamine metabolism to eradicate CDK4/6-resistant estrogen receptor positive breast cancer. The anticipated results are poised to pave the way for tailored therapeutic approaches that address the unique challenges posed by glutamine metabolism in the pursuit of more effective treatments for this subset of patients with limited options.